Defining interaction quantitative trait loci (iQTLs) in the human genome

Abstract
My research aims to understand the role of three-dimensional (3D) chromatin structure in gene regulation. This
involves studying associations among genotype, histone modifications, transcription factor binding, non-coding
RNAs, chromatin interactions and gene expression. In order to transform this genome-wide information into
new biological discoveries, my laboratory develops scalable and interpretable computational methods based
on statistics, graph theory and machine learning. Our recent focus is to address an important gap in the current
knowledge of the role of 3D chromatin structure in gene regulation. That is, we aim to define how genotypic
variation affects 3D organization of gene promoters, and in turn, their expression. To achieve this at a genome-
wide scale is an ambitious goal, because it requires having at a minimum, genotype, gene expression and
chromatin interaction profiles in pure populations of specific cell types from a large number of donors.
However, my laboratory is uniquely positioned to perform this research because: i) we are involved in a study
at the La Jolla Institute (LJI-R24AI108564) that has already genotyped ~100 donors and expression-profiled
more than 15 different pure populations of human immune cell types, and we have access to the same
samples for chromatin interaction mapping, ii) in collaboration with other groups at LJI, we have already
discovered a prototypical example of an interaction quantitative trait locus (iQTL) that alters and rewires
interactions from the promoter of a specific gene that is associated with asthma susceptibility, iii) we have the
necessary expertise and proven track record in experimental design and computational analyses of various
chromatin conformation capture assays. Leveraging the resources available at LJI and our expertise in the
field, we will build a unique research program around the novel concept of iQTLs. The emerging set of three
main questions we propose to address within the next five years are: Q1) How do we define cell-type-specific
iQTLs for common genetic variants? Q2) What is the extent of overlap between iQTLs and GWAS SNPs? Q3)
Can we build predictive models for the cell-type specificity of chromatin interactions and iQTLs? Although we
propose to define iQTLs only in two abundant, easily accessible, and highly disease-relevant immune cell
types, the concept of iQTLs is equally important in other cell types implicated in diseases with a genetic
component. Hence, the proof-of-concept developed by this work, without a doubt, will open up a new field in
studying a previously uncharacterized role for disease-susceptibility variants, specifically non-coding SNPs,
from genome-wide association studies (GWAS) in gene regulation.

Public health relevance
Narrative Recent discoveries that allow us to look beyond the one-dimensional sequence of DNA and understand the large-scale organization principals of its three-dimensional folding have been limited when it comes to characterizing the role of fine-scale genetic variations of the DNA code in controlling important cellular processes such as gene expression. This work will employ state-of-the-art molecular biology techniques and develop novel computational methods to define the role of such genetic variants in changing three-dimensional connections made by the promoters of genes in the human genome. This systematic and unbiased genome- wide study will have important implications in changing the way we study the disease relevance of genetic variation by revealing genotype dependence of long-range chromatin interactions between genes and their distal control switches at a scale that has not been achieved to date.